Mechanism and Impact of Dermal adipocyte remodeling in skin fibrosis

Summary
Chronic fibrosis is the pathological hallmark in a variety of disorders in many organs including the skin in patients
with systemic and limited sclerosis, aggressive fibromatoses, keloid, hypertrophic scarring, and atopic dermatitis.
Our laboratories recently uncovered an unexpected and intriguing role for mature adipocytes during skin fibrosis:
repression of ECM production. In particular, we identified that mature adipocytes undergo lipolysis to release
fatty acids in a Wnt-dependent mechanism and that adipocyte lipolysis is fibroprotective. Our findings are
important for several reasons. First, adipocytes have been shown to improve scarring yet how mature adipocytes
function in this process is unclear. Second, adipose tissue loss is a major clinical issue in the skin and an early
event in the development of skin fibrosis. Furthermore, adipocytes and their derivatives (fatty acids and/or
cytokines) are a tractable cell type to create a personalized therapy to promote healing in patients with fibrosis.
Through two focused and complementary Specific Aims, the work proposed in this application will take
advantage of multiple genetic mouse models that allow specific abrogation of adipocyte lipolysis and fibrosis
development, lipidomics, and fibroblast culture assays to define the function of adipocyte lipolysis during skin
fibrosis. Our goals are to test whether: 1. adipocyte-derived fatty acids abrogate ECM production during fibrosis
development; and 2. Wnts stimulate lipolysis of dermal adipocytes. Towards these goals, in Aim1, we will define
the cellular and molecular changes by which lipolysis alters mouse skin and if dermal adipocyte lipids can
abrogate the fibrotic response in mouse and human fibrotic fibroblasts or other cell types. In Aim2, we will test
the role of Wnts and its new candidate effector, Dipeptidyl dipeptidase 4 in stimulating lipolysis in chemical and
genetic models in vivo and in vitro. Results from these studies will provide a role for dermal adipocyte derived
fatty acids and Wnt signaling targets as new therapeutic targets in chronic skin fibrosis and associated
lipodystrophy.
Impact: We propose to study the function of adipocyte lipids and Wnt signaling induced lipolysis in context of
dermal fibrosis. These results will reveal novel cell types and molecular pathways involved in lipid depletion
that can be a key regulator of fibrosis development and reversal. Results from these experiments will elucidate
the contribution of intradermal adipocytes and lipolysis as new participants and will change the field by opening
new lines of inquiry and therapeutic targets.

Public health relevance
Project Narrative: A thorough understanding of cells and molecules that regulate tissue fibrosis is essential for the generation of tissue-specific regenerative therapies to effectively treat human disease. Since the manner in which adipocytes function during skin fibrosis is largely unknown, we will define how these major but poorly understood cells function during fibrosis using mouse models and human patient cells in culture. Our work will improve our understanding of the cells and molecules that control fibrosis development, how adipocytes function in this disease progression, and will have global relevance for other tissues like heart and lung that undergo fibrosis.